Promoting a Culture Of Innovation, Mentorship, Diversity and Opportunity in NCI Sponsored Clinical Research: NCI Research Specialist (Clinician Scientist) Award Application of Janice M. Mehnert, M.D.

Janice M. Mehnert, M.D., is the Associate Director (AD) for Clinical Research, Director, Melanoma and
Cutaneous Oncology and a tenured Professor of Medicine at the Perlmutter Cancer Center (PCC) of NYU
Langone Health/NYU Grossman School of Medicine. Here, she engages in significant efforts to promote
NCI-sponsored clinical research. She is active within NCI sponsored clinical trials networks, including
the National Clinical Trials Network (NCTN), where she serves as the Eastern Cooperative Oncology
Group-American College of Radiology Imaging Network (ECOG-ACRIN) Melanoma and Skin Committee
Co-Chair, and the Early Therapeutics Clinical Trials Network (ET-CTN), where she serves as site PI
overseeing PCC’s ET-CTN clinical trial efforts. She has conducted and published multiple investigator
initiated protocols, many with NCI support, and demonstrated a track record of mentoring junior investigators.
As AD, Dr. Mehnert is responsible for the supervision of clinical trial operations in Manhattan, Long Island (LI),
and Bellevue Hospital Center (overseeing site Medical Directors and Clinical Trials Office (CTO) Administrative
Directors and staff), CTO resource allocation, prioritization of PCC’s research protocols and oversight of PCC’s
12 Disease Management Groups (DMGs). She also completes strategic planning for future clinical research
activities including those at PCC’s Brooklyn campus. Since her recruitment to PCC, she has spearheaded the
reorganization of the clinical research infrastructure, decreased trial activation timelines, and assembled
resources to support Phase I trial activity at PCC-LI. She engaged PCC in NCI-sponsored initiatives to promote
equitable access to clinical trials. She successfully competed for funding for the Create Access to Targeted
Cancer Therapy for Underserved Populations (CATCH-UP) Program, which allowed her to rapidly activate 20
ET-CTN trials and assemble a prescreening infrastructure to navigate racially and ethnically diverse and
underserved patients to ET-CTN protocols. She subsequently led the integration of PCC into the Dana
Farber-Harvard Cancer Center Lead Academic Organization (UM1CA186709) as an Affiliate Organization.
In this application, she outlines plans to 1) Promote opportunities for PCC investigators to lead NCI-
sponsored clinical trials; 2) Promote accrual to NCI sponsored trials, including the submission of a NCTN
Lead Academic Participating Site (LAPS) grant, 3) Promote equitable access to clinical trials and 4)
Promote equitable access to research opportunities. She also outlines plans to improve communication
of trial offerings, increase access to precision medicine trials, and develop information technology
approaches to streamline research processes. The R50 Clinical Research Specialist Award would allow PCC
to protect Dr. Mehnert’s time to pursue these research activities. Her accomplishment of these goals will increase
access for PCC investigators and PCC patients to NCI sponsored trials and clinical research opportunities, a
significant reward for the PCC clinical research enterprise and the NCI clinical research mission.

Public health relevance
PROJECT NARRATIVE Janice M. Mehnert, M.D., Professor of Medicine, serves as the Associate Director for Clinical Research and Director, Melanoma and Cutaneous Medical Oncology at the Perlmutter Cancer Center (PCC) of NYU Langone Health/NYU Grossman School of Medicine, and in these roles devotes significant effort toward the promotion of NCI sponsored clinical research. She demonstrates a track record of funding, publications, and mentorship, and has launched several new initiatives to improve the process and innovation of clinical research at PCC. In this application, she outlines plans to support PCC faculty to lead NCI sponsored trials, to enhance accrual to these trials, to improve research processes for trial screening and accrual, and to promote diversity, equity, and inclusion in PCC’s clinical research efforts.